Elucidating underlying mechanisms in RIPK2-mediated toxicity following exposure to radiation

Radiation exposure can have detrimental effects to human health. Exposure to high doses of radiation can
provoke acute radiation syndrome within days and often results in death of the exposed. Exposure to
suboptimal doses of radiation does not result in acute radiation syndrome but can significantly increase the risk
of cancer in humans. Human activities such as medical treatment (x-rays, CT scans, radiotherapy), nuclear
power plant jobs, space explorations and warfare (atomic bombs) have made radiation exposure inevitable.
Most importantly relevant to this project, military personnel are directly involved in a number of these activities
and are at high risk for getting exposed to high levels of radiation that are detrimental to health. Thus,
understanding cellular and molecular mechanisms that proceed radiation exposure is critical for developing
new targeted therapies to treat radiation-induced illness. Specifically, how cytoplasmic sensors are involved in
radiation-induced illness is understudied. Our preliminary data demonstrate that RIPK2, independently of its
known receptors NLRC1 and NLRC2, provoke radiation-induced acute illness. WT mice succumb to 6.5-7Gy
lethal radiation within 2-4 weeks of exposure, whereas mice deficient in RIPK2 show not only delay in onset of
disease, but also significant protection from death with more than 50% mice surviving the endpoint of the
experiment. Interestingly, mice deficient in NLRC1 and NLRC2, the only known sensors upstream of RIPK2,
are hypersusceptible to the same 6.5-7Gy radiation dose when compared to WT mice. These NLRC1 and
NLRC2-deficient mice show early onset of disease, morbidity and mortality when compared to WT controls.
Furthermore, WT and RIPK2-deficient mice co-housing experiments suggest a potential role for microbiota in
radiation-induced lethality. These data highlight a central role for RIPK2 in promoting radiation-induced
lethality. In aim 1 – first, we will examine the distinct and opposite role of NLRC1 and NLRC2 vs. RIPK2 during
radiation-induced lethality in mice; second, we will determine gut epithelium intrinsic role for RIPK2 in radiation-
induced lethality; and third, we will investigate cell death pathways that are induced upon radiation and
examine the cell death pathways regulated by RIPK2 during radiation exposure. In aim 2 – first, we will
examine the effect of antibiotics and fecal microbiome transfer on the outcome of radiation-induced lethality in
WT and RIPK2-deficient mice; second, we will examine the effect of colonization of recipient host with WT- or
RIPK2-enriched bacteria; third, we will elucidate the fecal microbial landscape in WT and RIPK2-deficient mice
before and after radiation using 16S rRNA sequencing; and fourth, we will test the hypothesis that RIPK2
supports specific gut microbiota observed. Successful completion of these projects will elucidate cellular and
molecular mechanisms involving RIPK2-mediated illness observed in radiation exposed mice and hopefully
identify signaling nodes that can be targeted for therapeutics.

Public health relevance
Military personnel are involved in activities such as nuclear weapon testing (atomic veterans), nuclear power plant operation and nuclear accident cleanup that put them at high risk for radiation exposure. Radiation exposure can cause acute radiation syndromes associated with severe morbidity and mortality, and chronic long-term effects that culminate in development of cancer. The role of cytoplasmic sensors in radiation-induced acute radiation syndromes remain understudied. Here we examine the importance of RIPK2 signaling axis (an adaptor protein for cytoplasmic sensors NLRC1 and NLRC2) and RIPK2-associated microbiota in regulating radiation-induced acute sickness and death. Successful completion of this project will demonstrate a pathogenic role for RIPK2 in driving radiation-induced sickness.